GROWTH HORMONE SECRETORY FUNCTION IN CONSTITUTIONALLY SHORT CHILDREN

Determine whether dopaminergic and adrenergic agonist drug therapy accelerate growth velocity in healthy short children who do not meet traditional criteria for growth hormone (GH) deficiency.